Oral Chemotherapy Adherence Trajectories in Chronic Myeloid Leukemia

The paradigm of cancer treatment is changing as more treatments are administered in oral
form. This shift is well illustrated by the current recommended treatment of chronic myeloid
leukemia (CML). The 5-year survival rate for CML has doubled over the past two decade (31%
to 66%) in large part due to the discovery of targeted drugs, specifically tyrosine
kinase inhibitors (TKIs). In contrast to most cancer treatments that are administered by an
infusion in a controlled setting, TKIs are oral agents that require daily doses, most likely for life.
The individual with CML is responsible for administration of every dose of this life saving drug
every day. Although essential, adherence to TKIs is difficult; about a third of CML patients are
reported to be nonadherent. Effectiveness of TKI therapy is measured by cytogenetic and
molecular response and achievement of complete response is prognostic for long term-survival.
Adherence is associate with achievement of a complete molecular response and results in
improved overall survival. So why are a third of individuals with CML nonadherent? Specific to
CML, patients may miss TKIs due to distress from side effects and financial toxicity. Distressing
side effects from TKIs that reduce adherence include fatigue, pain, gastrointestinal upset,
swelling and skin rashes. Financial toxicity occurs due to the expense of the TKIs ($30,000-
$138,000/year) in combination with increasing insurance co-pays and out of pocket (OOP)
costs. For instance, Medicare Part D enrollees paid a mean OOP cost for TKI therapy of $8,503
in 2016. These high drug costs plus other OOP costs related to cancer care result in changes in
lifestyle, missed medical appointments and missed doses of medication. To more fully
understand adherence and the effects on clinical outcomes, we need to consider the intrapatient
and interpatient variability of medication adherence. This study will follow a group of 120
individuals taking TKIs for 12 months, measuring adherence with an objective measure
(Medication Event Monitoring System) along with monthly assessments of toxicity (side effects
and financial). To understand the variability of long term adherence, we will use these data to
determine subgroups of adherence patterns (or trajectories) over time using model-based
cluster analysis. Then, using both quantitative and qualitative data, we will examine how
different toxicities are associated with the different adherence patterns. Next we will examine
the influence of TKI adherence patterns on cytogenetic and molecular response. Identifying
differential patterns of adherence in individuals taking TKIs is important for identifying subgroups
at the highest risk of nonadherence and will support the design of targeted interventions.

Public health relevance
Project Narrative An increasing number of cancer treatments are now administered as oral agents that individuals are responsible to administer independently at home despite significant side effects and financial toxicity. This study of individuals being treated for chronic myeloid leukemia will describe trajectories of long term adherence to tyrosine kinase inhibitors and examine how these trajectories relate to side effects, financial toxicity, and clinical outcomes. Identifying differential trajectories of adherence is important for recognizing subgroups at the highest risk of nonadherence to support the design of targeted interventions.